Genomic Instability and DNA Repair

DESCRIPTION (provided by applicant): Support is requested for a Keystone Symposia meeting entitled Genomic Instability and DNA Repair, organized by Daniel Durocher, Jiri Lukas and Agata Smogorzewska. The meeting will be held in Whistler, British Columbia, Canada from March 1-6, 2015. Far from being a single process, genome maintenance involves the integration of multiple DNA damage repair and signaling pathways that are deeply influenced by cell cycle progression, chromatin composition, gene transcription, genome organization and the differentiation state of the cell. Preservation of genomic integrity is of paramount importance for cellular homeostasis, organismal development and tumor suppression. Accordingly, defects in the pathways that signal and repair DNA damage cause pathologies that include cancer, neurological disorders, premature aging and immunodeficiency. Our understanding of genome maintenance in the context of the multitude of intracellular transactions remains woefully incomplete and topic sessions addressing this issue will comprise a major theme of the conference. The program uniquely connects fields that otherwise rarely meet on a single occasion and will cover genome stability, development, disease, telomere biology and stem cell function. The meeting will highlight the latest trends including how genomic technologies have revolutionized our view of genome integrity and led to the discovery of new types of genome rearrangements whose mechanistic underpinnings remain largely unknown. The unusually broad scope of the conference will bring together scientists operating at the leading edge of multiple disciplines ranging from basic cell biology to pre-clinical oncology. Interactions between junior and seasoned investigators, as well as interdisciplinary contacts, will be fostered through poster presentations, workshops and plenary sessions, some of which are shared with the concurrent Keystone Symposia meeting on DNA Replication and Recombination, which will focus on the highly complementary theme of repair in the setting of DNA replication. Genome instability often drives tumor formation and progression, thus faithful genome maintenance is essential for tumor suppression. Topics of this meeting range from the basic mechanism of DNA repair responsible for prevention of genome instability, to discussion of how DNA repair pathways impact clinical oncology including treatment and drug resistance. These are perfectly aligned with the mission of NCI.

Public health relevance
PROJECT NARRATIVE The maintenance of genomic integrity is critical for cellular homeostasis and organismal development, and its disruption is a fundamental hallmark of cancer. The 2015 Keystone Symposia meeting on Genomic Instability and DNA Repair will gather a cross-section of established or emerging leaders from the various areas of genome maintenance research (DNA repair, telomere biology, genome sequencing, pre-clinical models and human genetics) along with investigators from fields that intersect the process of genome maintenance and DNA repair. The meeting aims to stimulate an integrated view of genome maintenance and to encourage investigators not usually associated with DNA repair to interact, collaborate and influence investigations in the field.